Perturbation-response approaches to determining the regulatory networks underlying human complex traits

Project Summary/Abstract
A large majority of heritable human traits and diseases are complex, with genetic variants of small effect spread
throughout the genome. It is now understood that genetic contributions to disease are enriched in gene promoters
and enhancers thought to regulate expression. This has led to the hypothesis that genetic variation leads to
disease via disruption of an underlying gene regulatory network, either via trait-relevant pathways or distal
perturbations propagating through the network to trait-specific core genes. At present, our lack of understanding
of the networks themselves limits our ability to understand how their disruption can lead to disease state. In the
long-term, causal models of these networks may reveal avenues for treatment by suggesting mechanisms for
returning the system to proper functioning. Here, I propose to leverage recent developments in causal inference to
show that novel computational methods enable integration across large-scale data generation efforts to highlight
regulatory changes underlying common disease. I propose to i) improve causal structure learning methods to
better leverage prior biological knowledge and improve network estimation for genes that are lowly expressed,
poorly captured or difficult to intervene on experimentally and ii) construct a causal network integrating populationscale eQTL data and GWAS summary statistics, and conduct a thorough comparative analysis with large-scale
CRISPR perturbation data in immortalized cell lines. The first aim will enable us to construct genome-wide causal
networks using single cell CRISPR screen data, including many functionally-relevant genes that are difficult to
capture using existing methods. Our second aim will enable identification of core disease-relevant genes and
their pathways, and allow us to identify which traits and disease pathways are best studied by current in vitro
immortalized cell line models. Completion of these aims will provide a framework for large-scale estimation of
regulatory networks and their role in complex trait biology.

Public health relevance
Project Narrative Genetic variation is now understood to contribute to complex disease through disruption of gene regulatory networks. However, our limited understanding of the nature of these networks makes it difficult to find mechanistic links between the genome and disease. In this proposal we will combine perturbation-response data with sophisticated causal inference algorithms to build large-scale networks integrating gene expression with complex traits, enabling improved understanding of the mechanisms underlying disease.